Data Management and Biostatistics Core

DATA MANAGEMENT AND BIOSTATISTICS CORE
SUMMARY
The Data Management and Biostatistics Core of this malaria research center will establish a robust, secure,
and comprehensive data management system to serve all research activities. The data management system
will include security features such as double data entry, date and time stamping of all data records with
electronic signatures, audit trails to track changes made to data and documents, quality assurance procedures,
and a reporting system for summary information and error reports. Standardized data collection and
processing procedures will be implemented across all projects. Data will be stored securely on a server in
Cameroon for online sharing among center investigators. The core will also provide bioinformatic support for
genomic data analysis and serve as a platform for data sharing across centers, following NIH guidelines.
Dedicated statisticians will provide biostatistical support at each step of research design, data processing, and
statistical analyses and assist with manuscript writing. This team will also offer training in biostatistics,
bioinformatics, and spatial modeling to participating scientists to help bolster their biostatistical capacity.